Evaluating perinatal mood and anxiety disorder in Kenyan: a mixed methods approach

ABSTRACT
This F32 project aims to advance understanding of perinatal mood and anxiety disorders (PMAD), their
consequences to infant social-emotional development, modifiable behaviors to alleviate PMAD, and preferences
for evidence-based PMAD management approaches. Approximately 20% of women worldwide report PMAD
during pregnancy or within the first year postpartum—predominantly depression, anxiety, and high stress.
Maternal PMAD increases risk of adverse infant outcomes. Risk of social-emotional developmental (SED) delays
is 60% higher among infants born to women experiencing PMAD compared to infants unexposed to PMAD.
Infant SED impacts mental health, social competence, and economic attainment throughout the lifespan. Little
is known about particularly influential timing of PMAD within the perinatal period which could optimize
intervention timing for maximal benefit to mother-infant dyads. Maternal engagement with infants through
interactive behaviors like playing, talking, and singing may mitigate mechanisms connecting PMAD and infant
SED delays. Low quality dyadic interactions are more likely with maternal PMAD and associated with suboptimal
SED. Interventions that increase mother-infant engagement quality improve infant SED, yet improvement to
maternal mental health is unclear. Gaps remain in understanding preferences for PMAD interventions among
pregnant and postpartum women in the sub-Saharan African region where PMAD disproportionately affects
women and maternal child health (MCH) clinics are widely attended, offering a high-impact access point for
maternal mental health services. The proposed F32 research project leverages data from an ongoing cohort
study (PrIMA-X, R01HD100201, PI: Pintye) among 1300 Kenyan mother-infant pairs followed from pregnancy
through 36-months postpartum with longitudinal assessment of maternal perinatal mood and anxiety disorder,
mother-infant engagement, and infant-child social-emotional development. In Aim 1, we will use dyadic data
collected monthly in pregnancy and 6-monthly through 36 months postpartum to prospectively assess impact
and timing of PMAD on SED delays among Kenyan mother-infant pairs. In Aim 2, we will determine the
relationship between mother-infant engagement and PMAD remission timing longitudinally through 36 months
postpartum, potentially highlighting an effective avenue for intervention. In Aim 3, we will evaluate acceptability
and preferences for PMAD management approaches among perinatal Kenyan women to inform patient-driven
intervention design using qualitative methods guided by the Theoretical Framework of Acceptability. This large-
scale mixed method study will contribute novel data toward informing a future PMAD intervention. The research
plan will provide the F32 candidate rigorous postdoctoral training including: 1) advanced epidemiologic and time-
to-event methods using longitudinal data with repeated measures, 2) experience with qualitative methods to
inform a patient-centered intervention, 3) content-area expertise in maternal-infant mental health—an area
critical to closing MCH gaps.

Public health relevance
PROJECT NARRATIVE One in five women experience perinatal mood and anxiety disorder (PMAD) during pregnancy and the first year postpartum, which adversely impacts linked relationship and health outcomes such as mother-infant engagement and infant social-emotional development, influencing dyadic consequences throughout the lifespan. This project leverages data from a large, multi-site, ongoing R01 to identify impactful timing, potential content, and preferences for PMAD management approaches among Kenyan women. This mixed methods study will inform future interventions tailored to African perinatal populations and provide opportunities for the F32 candidate to gain expertise in new methods and advance as an independent investigator improving health for mother-infant pairs globally.